A Registry-Based Study of Patterns of Use of Targeted Therapies for Metastatic Cancers in Diverse Populations

One of the most important cancer care advances in recent history is the rapid dissemination of targeted
therapies (molecularly targeted kinase inhibitors and immune checkpoint inhibitors) into the care of patients
with metastatic cancer. The marked expansion of indications for use of these novel therapies has been fueled
by growing enthusiasm among medical oncologists regarding their potential impact on survival for patients with
very poor prognosis. Although the survival benefit of these therapies is modest for most patients, a small
proportion experience long-term remission and potentially even cure of previously incurable cancer. Despite
the exciting promise of these therapies, they are very expensive – sometimes exceeding $10,000 per month.
Because of the high cost and high stakes of these therapies, it is critical to understand their patterns of use; yet
very little is known about targeted therapy use across diverse populations. Moreover, the impact of clinician
factors on variations in use is not known. In the absence of such knowledge it is difficult to develop effective
interventions to support equitable delivery of these therapies to the growing population of patients living with
metastatic cancer. Therefore, we will investigate patterns of use of targeted therapy among a diverse sample
of 2,240 patients diagnosed in 2019 with metastatic non-small cell lung cancer, genitourinary cancer, and
melanoma, and ascertained by the Georgia and Los Angeles county SEER registries. We will first characterize
patient factors associated with non-receipt, by creating a powerful combination of archival clinical and
sociodemographic registry data augmented with additional treatment data that SEER staff will collect directly
from clinicians and practices. We hypothesize that significant variations exist in patient use of targeted therapy
across age, race/ethnicity, socioeconomic status, and geography. We will then identify clinician factors that are
associated with tendency to prescribe targeted therapy. Informed by qualitative data that we will collect through
interviews with medical oncologists, we will survey the medical oncologists (clinicians) who treat these patients,
including many who practice in resource-limited settings. We will assess clinicians’ knowledge & attitudes
about targeted therapy, ask specific details about their practice setting, and use clinical vignettes to measure
their tendency to prescribe targeted therapy. We will survey 1025 clinicians and anticipate a 65% response
rate, based on our prior work. We hypothesize that certain clinicians are less likely to prescribe targeted
therapy, including those with less knowledge around targeted therapy and those who practice in resource-
limited settings. Finally, we will merge clinician data with patient data to quantify and explain the influence of
clinicians on variations in patients’ use of targeted therapy. We hypothesize that most (>50%) of the variation
occurs at the clinician level, and that clinician knowledge and attitudes drive most of the variation. The findings
from this study will inform the development of multilevel interventions to improve equitable receipt of targeted
therapies across diverse patient populations and practice settings.

Public health relevance
Project Narrative The surge of targeted therapies into the treatment of metastatic cancer has, in part, been fueled by growing enthusiasm among medical oncologists regarding their potential impact on survival for patients with very poor prognosis. Because of the potential for variations and disparities in access to and use of these high-cost, high stakes therapies, there is a critical and urgent need for population-level research about variations in use and the drivers of these variations. This study uses registry-based clinical, sociodemographic, and treatment data from a large population-based sample of diverse patients with metastatic non-small cell lung cancer, genitourinary cancer, and melanoma, as well as interviews and surveys of their treating medical oncologists, to examine potential variations and disparities in patient use of targeted therapies and to understand the contribution of clinician-level factors to these variations.